CORE B: Data Management Core

The overarching goal of our research consortium, entitled "PROVIDENT: PRepositioning Optimized Vaccine
strategies and Immunotherapeutics against Diverse Emerging iNfectious Threats," is to establish a
cooperative research center focused on the development of "plug-and-play" countermeasure strategies against
nairoviruses, hantaviruses, and paramyxoviruses. PROVIDENT is not only a highly interwoven collaboration in
itself—it also represents one potential spoke in a larger network of ReVAMPP centers. To create the high degree
of transparency and compatibility necessary to fully realize the potential for synergy within the ReVAMPP
network, it will be imperative to define a concise set of principles and standards to allow information to be shared
and processed in a uniform and consistent manner across all centers. Accordingly, we propose herein a
holistic data management approach that defines and adopts best practices to be implemented across
the ReVAMPP network. To create a formal framework of technical standards for data capture and transfer
ensuring data harmonization, reproducibility, consistency, and integrity and to establish network-wide sharing
policies fostering collaborations, best practices will be developed by our team in close cooperation with the
ReVAMPP Coordination and Data Sharing Center (CDSC) and other ReVAMPP Data Management Cores.
Centralized resources for data housing, management, and sharing will be established and will support cross-
center and cross-network confidential access to structural, biochemical, biological, and multi-omics data
generated by the center’s four research projects and three research cores. Our long-term goals are to maximize
data and resource accessibility in a standardized, organized, secure, reproducible, confidential, and flexible
manner and to establish central platforms promoting collaboration, cooperation, and streamlined knowledge
transfer. These resources will also help provide a roadmap for data management and harmonization in future
multicenter consortia.

Public health relevance
Please see Overall for Project Narrative.